PAIN RELIEF AND PHARMACOKINETICS OF RECTAL MS CONTIN

Evaluate whether patients who have achieved steady state analgesia with oral MS Contin will express equal satisfaction with their pain control with rectal doses of MS Contin.